Multi-scale analysis of Bacillus Calmette-Guérin (BCG) resistant tumor micro-environment in non-muscle invasive bladder cancer to identify novel therapeutic axis

Rationale: Non–muscle invasive bladder cancer (NMIBC) accounts for 70-80% of newly diagnosed bladder
cancer cases worldwide. Intravesical mycobacterium bovis Bacillus Calmette–Guérin (BCG) is the only US
Food and Drug Administration (FDA)-approved first-line treatment option for high-risk NMIBC. Intravesical BCG
targets the tumors by activating the mucosal anti-tumor immunity in the bladder tumor microenvironment (TME)
and this involves intricate molecular interactions within and between distinct cell populations manifesting in
different regions of the tissues. To this end, a comprehensive molecular atlas of NMIBC TME is needed to
dissect the cellular and spatial features, and ultimately the crucial signaling cascades amongst these features
that underlie the BCG resistance. Single-cell and spatially resolved sequencings hold promises to reveal the
near-cellular resolution snapshots of the BCG resistant TME. Current studies on NMIBC TME, however, are
often focused on the after-mass of BCG treatments, dominated by the muscle-invasive bladder cancers, are
based on small numbers of samples (< 15), and mostly focus on each –omics data modality. Overall, a holistic,
data-driven molecular model of NMIBC BCG resistance is lacking, which hinders the systematic search for the
therapeutic axes. Method: In this study, we will generate tissues from BCG-treated NMIBC tumors from the
responsive and unresponsive patients before BCG (pre-BCG) and after BCG (post-BCG) to explore these
therapeutic axes. Specifically, we will elucidate the spatial and cellular landscapes of BCG-resistant NMIBC
TME through i) matched single-nuclei RNA and ATAC sequencing, and near-cell resolution spatial sequencing
across 36 samples, and ii) bulk RNA sequencing across 132 samples to validate single-nuclei and spatial
findings and provide robust transcriptional readouts with the larger sample size. These data will be
systematically utilized to construct cell type-resolved gene network models to survey de novo BCG
resistance mechanisms and regulators, and repurpose pre-clinical or FDA-approved drugs to abolish
multi-facetted BCG resistance. Expected Results: To our knowledge, this is the first effort to simultaneously
study cellular genomic, epigenomic and spatial features of BCG-unresponsive NMIBCs. The altered cellular
and spatial changes from each type of sequencing data will be integrated into the cell type-resolved multi-scale
network model to elucidate their inter-wined signaling cascades as novel BCG resistance mechanisms and
their regulators. Ultimately, these mechanistic insights will inform the identification of pre-clinical and FDA-
approved drugs to target the BCG resistance regulators, and these will be validated in immune competent
tumor explants model to observe their anti-tumor efficacies. Overall, this study will yield valuable resources
of high resolution sequencing data to elucidate the NMIBC TME, and address the clinical unmet needs
to tackle BCG resistances in NMIBC.

Public health relevance
Project Narrative: Intravesical Mycobacterium bovis Bacillus Calmette–Guérin (BCG) is the only US Food and Drug Administration (FDA)-approved first-line treatment option for high-risk Non-muscle invasive bladder cancer (NMIBC), and yet ~55% of patients experience the therapy resistance. Through generating molecular atlas of single-nuclei RNA & ATAC sequencing, near-cell resolution spatial transcriptome, and bulk RNA sequencing on retrospective cohort of pre- and post-BCG patients, we will generate multi-scale molecular network models integrating multi-omics data at cellular resolutions. These will generate de novo BCG resistance mechanisms, regulators and identify drugs to abolish the BCG resistance axis to shed light on the currently unmet clinical needs.